Extraordinary Dispersion Engineering In Enabling Ultrafast Swept Source visiblelight Optical Coherence Tomography

Project Summary
This SBIR Phase 1 project focuses on developing, characterizing, and validating a new swept-source laser
system to enable the next-generation clinical visible-light optical coherence tomography (vis-OCT). We will
develop a novel design of photonic bandgap fiber that comprises Fiber Bragg Grating array to temporally
disperse broadband picosecond-pulses to create a wavelength sweeping pulse train. The new swept source can
operate up to tens of MHz frequencies without mechanical moving parts, enabling ultra-high-speed swept-source
vis-OCT (SS-vis-OCT) for the first time. The new light source will also enable truly shot-noise-limited performance
in vis-OCT while mitigating the artifacts caused by both eye motions and fringe washout. During the project
period, we will design, fabricate, and optimize the new swept-source laser to achieve the desired sweeping
frequency, bandwidth, and phase stability. We will further develop a prototype SS-vis-OCT and fully test its
performance in phantom eyeballs, ex vivo bovine eyes, and blood vessel phantoms.

Public health relevance
Project Narrative This proposal aims to enable the next-generation visible-light optical coherence tomography (vis-OCT) by developing a new swept source laser. This new laser will permit the first swept source vis-OCT (SS-vis- OCT), improving the imaging speed by at least 20 folds and eliminating the intrinsic noise in current vis- OCT systems.